Training in Cellular, Molecular and Biomedical Studies (CMBS)

ABSTRACT
The Integrated Program in Cellular, Molecular and Biomedical Studies (CMBS) is an umbrella program that
presents students with a unique opportunity to obtain individualized training in all aspects of biomedical sciences,
including basic cell and molecular biology, microbiology, structural biology, biophysics, genetics, immunology,
neurobiology, systems and computational biology, as well as translational biomedical disease-related research.
The underlying rationale for this program was to provide graduate students with a thorough grounding in the
basics of biochemistry, genetics, cell and molecular biology through a series of ‘core courses.’ With the aim of
expanding and unifying the graduate programs, the CMBS program has been expanded to include not only an
umbrella track, but also tracks in Structural Biology/Molecular Biophysics, Cell Biology/Stem Cell Biology,
Microbiology and Immunology, Pathobiology and Mechanisms of Disease, Cancer Biology and Systems Biology.
All the students in these tracks take the same ‘core courses’ and then choose elective courses specific to the
tracks. One of the unique aspects of the CMBS program is that students can elect to stay in the “umbrella” track,
thereby allowing them to choose their own program of courses that fit their interests. For the core courses,
trainees will take courses in biochemistry, cell and molecular biology, molecular genetics and statistics. They
will take courses in responsible conduct of research, and training in rigor and reproducibility. They will have
many opportunities to present their research and will submit a first author paper before they graduate. Students
in this training program will learn to evaluate and analyze biomedical literature critically and identify important
biomedical research questions. They will also assess the significant questions and to determine if the research
questions were approached rigorously, develop an independent research plan with rigorous and reproducible
experimental design, quantitative approaches and data interpretation and identify rules of responsible conduct
of research. As part of their training they will learn to perform research independently, responsibly and rigorously
and conduct work both individually and as part of a research team. Upon completion of the training program,
they will be able to present research to a wider audience, both in oral and written presentations and evaluate the
possible careers in biomedical research that are available upon graduation. The CMBS Program hosts a student
research seminar series and a biennial student faculty retreat. Most students graduated in 5-6 years. We plan
to support eight students for two years during their first two years of graduate study. The CMBS Program remains
the premier cellular and molecular biology graduate program at Columbia University Medical Center and support
from this Training Grant is crucial for the continued success of this program.

Public health relevance
PROJECT NARRATIVE The goal of the Integrated Program in Cellular, Molecular and Biomedical Studies is to provide students with a unique opportunity to obtain individualized training in basic cell and molecular biology, microbiology, structural biology, biophysics, genetics, immunology, neurobiology, systems and computational biology, as well as translational biomedical disease-related research. They will receive training in responsible conduct of research and learn how to do rigorous and reproducible research.